Cell & Molecular Imaging Core

Project Summary
The URMC IDDRC Cell and Molecular Imaging Core (CMI Core) provides IDDRC members with
access to advanced imaging, analysis, and viral vector-based transduction methods, as well as
corresponding faculty expertise, to support in vitro and in vivo study of phenomena at the
subcellular, cellular, tissue, and whole animal scale. The capabilities provided are central to
research conducted by IDDRC investigators who have been using the available techniques to
study subcellular, cellular, and systems level processes in the developing brain of animal models
and humans. The integration of these cutting edge methods with expert faculty guidance ensures
and streamlines access to techniques and equipment that are fundamental to IDD research.
State-of-the-art imaging equipment and software provides a spectrum of image acquisition and
analysis approaches (confocal, multiphoton and super-resolution imaging) and our viral vector
facility designs and produces custom viral approaches for both labeling and manipulating
signaling pathways for in vitro and in vivo imaging and analysis. The CMI Core is supported by
dedicated administrative and technical faculty and staff to provide customized, critical technical
expertise in the design, implementation, and analysis of studies involving microscopy that span
the interests of the IDDRC faculty. The CMI Core leverages existing expert faculty and staff and
long-standing infrastructure (confocal, multiphoton, analysis), with a proven track record of usage
by IDDRC investigators, with newer capabilities (super-resolution, viral vectors), which have been
implemented based upon recognized needs. The result is a CMI Core that allows IDDRC
investigators to design and implement meaningful experiments using cutting edge technologies
and efficient analysis paradigms to address difficult and diverse biological problems.